Single Cell Transciptomics of the Opioid Use Disorder and HIV Syndemic in the Human Brain

Blood vessels that vascularize the central nervous system possess unique properties, termed
the blood-brain barrier (BBB), which imposes a tight regulation of molecules and cells
(particularly immune cells) that move between the blood and the brain. Disrupted BBB may
increase immune cell infiltrating into the brain parenchyma and promote glial activation,
increased inflammation and neurotoxicity. Interestingly, increased permeability of BBB has been
implicated in the progression of Alzheimer's disease. Differential gene expression among cell
types, and among individuals likely contributes to selective vulnerability or resilience. This
proposal will use single nucleus RNA sequencing to elucidate cell type selective transcriptomes
in leptomeninges and associate immune cells from AD and control cases. This work will lead to
fundamental advances in our knowledge of cell type specific genes regulating the
pathophysiology of neurovasculature and associate immune cell types in AD.

Public health relevance
This proposal will identify genes involved in neurovasculature and associated immune cells that contribute to disease progression in Alzheimer's disease; these approaches could lead to novel gene therapies to control and perhaps reverse the relentless brain degeneration that causes dementia.